Core B - Translational regulation and medicinal Chemistry

Core B. Translational Regulatory Affairs and Medicinal Chemistry Project Abstract The Translational Regulatory Affairs and Medicinal Chemistry Core will serve as an essential resource for the project teams by creating a consolidated process for the preparation and submission of documents for regulatory review by local, state, and federal agencies; by expediting the approval of new clinical modalities; by providing guidance and referral on aspects of clinical chemistry and cGMP; by facilitating industry and institutional interactions; and by insuring the inventor(s)'s and institution's interests in novel discoveries are protected.

Public health relevance
Core B. Translational Regulatory Affairs and Medicinal Chemistry Project Narrative The Translational Regulatory Affairs and Medicinal Chemistry Core will serve as an essential resource for the project teams by creating a consolidated process for the preparation and submission of documents for regulatory review by local, state, and federal agencies; by expediting the approval of new clinical modalities; by providing guidance and referral on aspects of clinical chemistry and cGMP; by facilitating industry and institutional interactions; and by insuring the inventor(s)'s and institution's interests in novel discoveries are protected.